OCTA and Glaucoma Progression in the Non-Human Primate

DESCRIPTION
Glaucoma is a group of diseases that results in a pathological loss of retinal ganglion cells (RGC) and irreversible
vision loss. Increased intraocular pressure (IOP) is a major risk factor for glaucoma, but some individuals with
elevated pressures never develop disease, and others with low pressures progress to blindness. Similarly, in the
non-human primate experimental glaucoma model, animals with similar IOP profiles are shown to have
significant differences in the extent and rate of retinal nerve fiber layer (RNFL) thickness loss. Both clinical and
experimental models suggest that in addition to IOP, other factors need to be considered for glaucoma
progression. We hypothesize the variability in disease progression can be explained by vascular factors. The
retina is one of the most metabolic tissues in the body, and it is unknown if eyes with relatively lower vascular
volume, or eyes that show greater change in perfusion with changes in IOP are at greater risk of pathology.
Furthermore, although eyes with optic neuropathy have reduced vascular density, it remains unknown if there
are changes in retinal vasculature that precede RGC loss. Optical coherence tomography angiography (OCTA)
is a non-invasive method for three-dimensional vascular perfusion imaging. However, analysis of OCTA imaged
vasculature is based on slab projections, where the three-dimensional nature of tissue is lost. In addition, OCTA
vascular perfusion is often considered a static measure, but vascular flow velocity has temporal properties. For
this project, we have optimized OCTA scans to quantify vascular volume and vascular volume density, and using
sequential and registered scans, OCTA temporal variability. In the non-human primate experimental glaucoma
model, we will determine; 1. if the rate of disease progression is related to baseline global and regional measures
of vascular volume / volume density and regional OCTA temporal variability, 2. if there is loss of vascular volume
prior to inner retinal thickness, 3. if the rate of structural and functional changes are is related to the extent to
which vascular perfusion changes with IOP challenge, and 4. using post-mortem tissue, define vascular anatomy
(pericyte coverage, endothelial cell density, capillary basement membrane thickness/integrity) in healthy and
disease eyes and association with in vivo OCTA measures. Successful completion of these aims will establish if
vascular measures as quantified using OCTA can be used to determine risk of pathology, and rate of glaucoma
progression.

Public health relevance
PROJECT NARRATIVE Glaucoma is a group of diseases that damage retinal ganglion cells, and can lead to irreversible blindness if left untreated, and as the world's population ages, it has been estimated that the global prevalence of glaucoma will reach at least 111 million individuals by 2040. While reduction of intraocular pressure can slow disease progression, patients with low pressure can progress to blindness. In this project, we will determine if non- invasive measures of the eyes vascular and how it responds to changes in intraocular pressure are determinant factors for glaucoma progression.